Health and Functioning in New Midlife Adults: Understanding the Role of Alcohol Use, Social Environments, and Preventive Intervention over the Life Course

ABSTRACT
Significant transitions at midlife can be positive for some, but many also experience emotional challenges,
physical health declines, and high stress in adapting to new social roles. Yet, health and functioning at midlife
have received less attention compared to older ages because disease and disability remain relatively rare. This
combination of growing health challenges and low rates of disability points to opportunities for intervention to
prevent and delay more serious illness and impairment. This study addresses important gaps in knowledge to
better capitalize on these opportunities. Little is known about how midlife may be different for those now in their
40s and 50s—often labeled Generation X—who are much more diverse demographically and in their family
formation and education/career paths than prior generations. Most existing midlife research has also focused
on relatively narrow health outcomes with little consideration of the interplay of physical and mental health and
functioning in work and civic life. Recent studies showing significant health declines in new midlife cohorts
additionally underscore the need for a focus on disparities and sociodemographic differences in midlife health
and mechanisms to explain them, particularly increasing alcohol misuse and its central role in midlife health
risks. This study brings strengths to examining these issues by drawing on existing longitudinal data from the
Seattle Social Development Project (SSDP) and collecting new data in early midlife. SSDP has followed a
gender-balanced, multiethnic, and socioeconomically diverse panel of 808 participants across 15 waves from
age 10 to 39 with high retention. Data include theory-guided assessments of the social environment
throughout; unique longitudinal assessments of neighborhood environments that integrate self-report, Census,
and GIS measures; and longitudinal measures of alcohol and other substance use and disorder, mental and
physical health, and functioning in work, community, and civic life. New data augment and extend existing
measures into midlife and enable the examination of midlife-specific experiences. The study aims are to
examine (1) how sociodemographic statuses and transitions among those now entering midlife influence
comorbid health outcomes in early midlife; (2) how alcohol use, misuse and related behaviors during midlife
influence midlife health, as well as the influence of life course trajectories of alcohol use and misuse leading up
to midlife; (3) how malleable social and neighborhood environmental factors influence alcohol use and misuse
over the life course and, in turn, affect midlife health; and to (4a) examine the long-term malleability of social
environmental factors from early adolescence to midlife by testing the mechanisms of a childhood intervention
(embedded in the existing study); and (4b) identify promising adult intervention targets by conducting focus
groups with participants to help design and tailor prevention programs. With guidance from empirical findings
and participants themselves, the goal of the study is to provide researchers and health practitioners with
specific recommendations for preventive interventions addressing public health priorities for midlife adults.

Public health relevance
Project Narrative This study examines the influence of sociodemographic statuses and transitions among those now entering midlife on comorbid health outcomes in early midlife, as well as the role of life-course alcohol use and social and neighborhood environments for midlife health. Drawing on longitudinal data from a diverse community sample from age 10 to 47, the study investigates the long-term malleability of environmental factors and seeks to identify promising intervention targets to design and tailor prevention programs from early adolescence to midlife. The goal of the study is to provide midlife researchers and health practitioners with specific recommendations for preventive interventions addressing public health priorities for midlife adults.